Mechanistic studies of human transporter Sialin

The direct cause of free sialic acid storage disorder is the genetic mutation in the lysosomal sialic acid transporter
Sialin. Although the disease has been discovered for over 20 years, no cure has been developed. The long-term
goal is to help create valuable therapeutics for patients with pathogenic Sialin mutations. The overall objective
of this proposal is to establish a basic understanding of the membrane transporter. The rationale is that, with
detailed knowledge about the structure-function relationship of Sialin, it will be possible to design small molecules
to restore the substrate translocation of dysfunctional Sialin. To accomplish the goal, three specific aims will be
pursued: 1) understand the substrate translocation mechanism of Sialin; 2) probe the connection between
defective Sialin and cardiovascular diseases; and 3) restore the transporter function of pathogenic Sialin mutants.
Specifically, in the first aim, biochemical assays, cryo-electron microscopy, and molecular dynamics simulation
will reveal the molecular mechanism. In the second aim, Sialin will be characterized in human cardiac cells and
a human induced pluripotent stem cell-based platform. In the third aim, small molecules to rescue dysfunctional
Sialin will be identified by high-throughput screening and confirmed by secondary and tertiary assays. The
research proposal is innovative because it focuses on finding a new strategy to rescue the normal function of
pathogenic Sialin mutants that are directly connected with human diseases. This proposal is significant because
it is expected to reveal the basic molecular mechanisms of Sialin and provide scientific justification for further
development of drugs against various pathogenic Sialin mutations.

Public health relevance
The proposed research is relevant to public health because it seeks to improve our fundamental knowledge about the disease-causing transporter Sialin and develop a new strategy to rescue dysfunctional pathogenic Sialin mutations. The results will have the potential for future pharmaceutical development to treat related human diseases, such as free sialic acid storage disorder, heart failure, and even Parkinson’s. Thus, the proposed research is relevant to NIH’s mission.